MECHANISMS OF DRUG DEPOSITION IN HAIR

DESCRIPTION (Adapted from the application): Workplace drug testing has now become fairly commonplace as a surveillance procedure in the American workplace. Hair testing has the potential to offer numerous advantages over urine and serum testing; some of those being 1) reduced cost; 2) convenience of sample storage and shipment; and 3) reduced psychological stress for the test subject. Despite these potential advantages, hair testing, however, has yet to become an accepted procedure due to unresolved issues as: 1) efficacy of drug extraction from hair; 2) differentiation between drugs contacted externally on the hair versus drugs ingested and deposited via the systemic circulation; 3) the effects of sweat and sebum on quantitation of hair drug levels; 4) correlation between ingested drug and distribution into hair; and 5) effects of pigment in hair deposition. The last issue may be the most important primarily because hair pigment in drug disposition has raised issues regarding differential sensitivity in and between various ethnic groups. In addition, gender bias may be significant when hair treatments such as dyes and salon treatments have the potential to remove or chemically alter or destroy deposited drugs. During the previous granting period, the investigators have accomplished the following objectives:(1) quantitation of hair growth rate via incorporating daily injections of rhodamine and measuring distance between fluorescent bands deposited in hair. Accessible water space was determined using a stage micrometer and equilibration of hairs with tritium oxide of known specific activity; (2) serum constituents as [C-14]urea, [Ca-45]calcium+2, [Cl-36]chloride- were quantitated and differences were noted in differentially pigmented hair; (3) highly covalently bound [S-35]cysteine was quantitated and a difference was noted in pigmented vs. less-pigmented hair. It was found that essentially no cysteine could be liberated on 24-hour extraction, consistent with possible covalent incorporation into hair matrix; (4) studies with fentanyl (as opposed to [H-3]-d-amphetamines and a benzoyl esterified amino alcohol, a model of cocaine) demonstrated that systemic delivery was not dose related, larger concentrations were extractable following external exposure, and "capping" of surface amino and hydroxyl groups resulted in significantly decreased, suggesting an interaction with hair chemical functionalities. Thus, a difference and a mechanism for fentanyl incorporation into hair via external and systemic route were semi-quantitatively determined. Studies were also accomplished with labeled cocaine, nicotine, and flunitrazepam; and (5) sodium sulfide digestion resulted in significantly greater recovery of base-stable drugs than NaOH.